Neuronal RNA processing defects in ALS4 caused by SETX mutations

DESCRIPTION (provided by investigator): We have discovered mutations in the senataxin gene (SETX) as the molecular basis of a juvenile-onset, autosomal dominant (AD) form of familial amyotrophic lateral sclerosis (ALS). This form of ALS, known as ALS4, is an essentially pure motor systems disorder characterized by limb weakness, severe muscle wasting, pyramidal signs, and slow relentless disease progression. Senataxin is a large 2677 amino acid protein which contains a conserved superfamily 1, DNA/RNA helicase (of ~ 500 amino acids) in the C-terminus, strongly suggesting a functional role in RNA processing. While the precise function of senataxin remains unknown, the most compelling evidence including more than 10 years of functional studies of the yeast ortholog sen1p suggest these proteins function in several RNA processing events including RNA Pol II transcription termination of short < 500-nt transcripts. As it turns out, altered RNA processing in neurodegeneration is well established including loss of SMN in spinal muscular atrophy (SMA) and loss of FMRP in fragile-X mental retardation. However, the recent discovery of the involvement of TDP-43 and FUS in familial and sporadic ALS (FALS and SALS) reemphasizes the role of altered RNA processing in ALS. To further study the role of SETX mutations in ALS4 we have created a number of important reagents including transgenic (Tg) and gene targeted mice. We will also isolate neuronal RNA directly from tissue to characterize RNA processing pathways that are aberrant in ALS4 and other FALS/SALS forms. To further our understanding of this form of FALS we recently established Tg mice expressing R2136H mutant senataxin at high levels from the mouse prion promoter (PrP). These R2136H Tg-mice display a motor deficit by rotarod and strength testing beginning at 6-8 months of age. In addition, we have generated Setx gene-targeted mice by introducing a second ALS4-associated mutation, L389S. The L389S KI-mice show a more severe but later onset hind-limb paralysis (~ 12-13 months age) with apparent reduced survival rates. Therefore, we propose to thoroughly characterize these SETX murine models via molecular genetic analysis, behavioral testing, histopathology, immunofluorescent and electron microscopy. Next, we aim to define the subset of neuron expressed RNA transcripts (coding or non-coding) misregulated in response to ALS4 associated SETX mutation. Transcripts identified as most affected by SETX mutation will be validated by quantitative RT-PCR and the role of SETX in transcription termination in specific transcript classes will be tested. In additional experiments we will test if the different RNA processing pathways found to be affected in ALS4 might also be affected in other forms of motor neuron disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Narrative Mutations in senataxin (a DNA/RNA helicase) are known to cause of two severe, debilitating neurodegenerative conditions, ALS4 and AOA2. This underscores the importance of senataxin function in the survival of various neuronal populations. Our studies seek to determine the molecular mechanisms leading to motor neuron loss in ALS4 and further characterize the Narrative Mutations in senataxin (a DNA/RNA helicase) are known to cause of two severe, debilitating neurodegenerative conditions, ALS4 and AOA2. This underscores the importance of senataxin function in the survival of various neuronal populations. Our studies seek to determine the molecular mechanisms leading to motor neuron loss in ALS4 and further characterize the emerging role that aberrant neuronal RNA process may play in both sporadic and familial motor neuron disease. __SpecificAimsTextDelimiter__ SPECIFIC AIMS In 2004, we discovered that mutations in the senataxin gene (SETX) are the cause of a juvenile-onset, autosomal dominant form of familial amyotrophic lateral sclerosis (ALS). This form of ALS, known as ALS4, is an essentially pure motor systems disorder characterized by limb weakness, muscle wasting, pyramidal signs, and relentless disease progression. Intriguingly, recessive loss-of-function mutations, also identified in SETX, lead to a severe form of inherited ataxia, known as Ataxia-Oculomotor Apraxia Type 2 (AOA2). Together, these findings reveal an exciting genotype/phenotype correlation for SETX mutations and establish senataxin as an important protein for neuron survival. Senataxin contains a conserved superfamily 1, DNA/RNA helicase domain in the C-terminus, indicating a key role in RNA processing. While its precise function remains unknown, compelling evidence suggests that senataxin regulates RNA Polymerase II transcription termination of short transcripts. As it turns out, altered RNA processing is a well known cause of neurodegeneration, as observed with loss of SMN in spinal muscular atrophy (SMA), and for loss of the FMR1 protein in fragile-X syndrome. Furthermore, the recent discovery of a role for TDP-43 and FUS in familial and sporadic ALS reveals that altered RNA processing may be a common basis for ALS disease pathogenesis. We have developed a variety of important reagents, including a senataxin polyclonal antibody, and two sets of senataxin transgenic and gene-targeted mice. We propose to use these materials to characterize RNA processing pathways that are aberrant in ALS4, and to determine if ALS4 RNA processing defects occur in other forms of ALS. These goals will be sought by pursuit of the following specific aims: Aim 1: We will determine if our transgenic and gene-targeted senataxin mice recapitulate the ALS4 phenotype by completing a comprehensive characterization of these mice. Using a murine prion protein transgenic expression vector, we have established independent lines of SETX transgenic mice that express either normal or mutant senataxin protein containing the R2136H ALS4 substitution. Furthermore, we used gene targeting to knock-in a different ALS4 disease mutation, L389S, into the endogenous Setx locus. Preliminary results indicate that mice expressing mutant senataxin are developing expected neurological phenotypes. We will characterize these SETX murine models via molecular genetic analysis, thorough behavioral testing, histopathology, immunohistochemistry, and electron microscopy. Aim 2: We will test the hypothesis that a subset of motor neuron-expressed transcripts are misregulated in ALS4 transgenic and knock-in mice by cataloguing their transcriptomes. RNA will be isolated directly from lumbar spinal cord neurons via Laser Capture Micro-dissection (LCM) preventing the need for sample amplification. RNA will be isolated from non-transgenic controls and from the following specific ALS4 lines: (i) Setx knock-in (SETX L389S); (ii) PrP SETX; and (iii) PrP SETX-R2136H. In collaboration with Dr. Gene Yeo at our institution, we will use high throughput sequencing (HTS) to identify transcripts whose expression and/or processing are altered in ALS4 motor neurons. This RNA-Seq analysis will reveal significant changes in the levels of coding and non-coding RNA species, and after validation by quantitative PCR, we will analyze altered RNA data sets to test if certain pathways or gene ontology sets are predominantly involved in ALS4 disease pathogenesis. We will also test if mutation of SETX results in altered transcription termination. Aim 3: We will test the hypothesis that altered RNA expression and processing events in ALS4 are present in other forms of motor neuron disease by examining the status of these putative RNA targets in related motor neuron diseases. To evaluate the role of altered RNA processing as a common theme in motor neuron diseases, we will determine if pathways subject to altered RNA expression and processing in ALS4 are also perturbed in related ALS motor neuronopathies. Although it is unclear if dominant TDP-43 (ALS10) or FUS (ALS6) mutations lead to gain- or loss-of-function, it appears likely that loss of their normal RNA binding functionsare disrupted when they are sequestered into nuclear and/or cytoplasmic aggregates, or mislocalized. We will thus test if the altered RNA processing and RNA expression patterns that we identify in ALS4 motor neuron degeneration are also affected in FALS/SALS patient samples and mouse models of motor neuron degeneration.